ISOLATION AND CHARACTERIZATION OF VOLUNTARY MUSCLE CELLS IN VITRO

eletal muscle cells have been isolated from the fetal and adult human urces. They have been maintained in vitro and will be studied as to their itial characterization.